Overcoming Antigen-Low Tumor Escape in Non Small Cell Lung Cancer with Chimeric TCR T Cell Therapy

ABSTRACT
CAR-T cell therapy has revolutionized the treatment of hematological cancers but has yet to achieve durable
efficacy in more common solid tumors, such as non-small cell lung cancer (NSCLC). In a phase I trial
evaluating CAR-Ts targeting the tumor-associated antigen ROR1, we observed limited efficacy due to CAR-T
exhaustion and heterogeneous ROR1 expression on tumors, which led to the escape of antigenlow/null tumors
even in transient responders. To address these challenges, we developed an autochthonous model of ROR1+
NSCLC (KPROR1), which recapitulates the suppressive tumor microenvironment (TME), heterogeneous ROR1
expression, and CAR-T exhaustion observed in patients. We found that enhancing T cell function by
overexpressing the AP-1 transcription factor c-Jun improved response to PD-L1 blockade but failed to prevent
escape of ROR1low/null tumors, emphasizing the need for strategies that both preserve CAR-T function and
control escape of antigenlow/null tumors.
To enhance CAR-T sensitivity, we engineered chimeric TCRs (ChTCRs), which fuse a CAR single-chain
variable fragment (scFv) to a TCR constant chain. ChTCRs show superior sensitivity to antigenlow tumors and
outperform CAR-Ts in vivo in models of B cell malignancies. Moreover, bi-specific ChTCRs targeting two
antigens outperform optimized bi-specific CAR-Ts, suggesting they may be more effective than CAR-Ts at
controlling heterogeneous solid tumors. However, while ChTCRs do not require synthetic costimulation for
efficacy in B cell malignancies, their activity in solid tumors may be limited by insufficient co-stimulation in the
suppressive TME. To overcome this barrier, we designed novel co-stimulatory receptors that convert inhibitory
PVR-TIGIT signals into activating signals and enhance ChTCR-T function in vitro. Since co-stimulation partially
relies on AP-1 activation, overexpression of c-Jun could further amplify the favorable effects of co-stimulation.
I hypothesize that ChTCR-Ts will be more sensitive to ROR1low tumors in vivo than CAR-Ts, and that
co-expression of co-stimulatory receptors targeting the PVR/TIGIT axis will synergize with c-Jun
overexpression to enhance ChTCR-T activity, enabling more effective control of tumors with
heterogeneous ROR1 expression. In this proposal, I will: 1) assess ChTCR-T activity against ROR1low
tumors in the KPROR1 model relative to CAR-Ts and identify barriers to efficacy, and 2) determine whether the
co-stimulatory receptors I designed synergize with c-Jun to enhance ChTCR-T function and response to PD-L1
blockade. These studies will reveal the barriers to ChTCR-T efficacy in vivo and potentially identify strategies to
control escape of heterogeneous lung tumors. Through this fellowship, I will gain expertise in tumor
immunology, computational biology, and preclinical mouse models, equipping me to advance immunotherapies
by integrating fundamental research with clinical practice.

Public health relevance
PROJECT NARRATIVE CAR-T cell therapy has induced dramatic responses in blood cancers, representing one of the most remarkable therapeutic advances in the past decade, but efficacy in more common solid tumors like lung cancer has been limited by loss of CAR-T function and escape of tumors that turn-down expression of the CAR target. We designed novel receptors, termed chimeric T cell receptors (ChTCRs), that enable T cells to kill tumors that escape detection by CAR-T cells. In this proposal, we will use a clinically relevant model of human lung cancer to investigate whether ChTCR-Ts, either alone or in combination with other innovative strategies to improve their function, are more effective than CAR-Ts at controlling heterogeneous tumors, providing a strategy to prevent tumor escape and enhance durable efficacy that can be readily translated to the clinic to improve patient outcomes.